Clinical Trial

The conduct of high quality clinical trials is essential to the overall mission ofthe UC Davis Cancer Center. The Clinical Trials Support Unit (CTSU) is a shared resource providing coordination/supervision of clinical research activities, centralized protocol development/implementation, data management, regulatory oversight/review, quality control, and centralized navigation services. CTSU activities are complementary to and integrated with the Protocol Review and Monitoring System (PRMS) described separately in this application.

Public health relevance
The Clinical Trials Support Unit provides staff expertise needed to conduct cancer clinical trials, to protect patient safety, maintain the integrity of data collected, respond to regulatory requirements of the University, the National Institutes of Health, trial sponsors, and the Food and Drug Administration, and assure effective communications among the clinical trial team. Thus, it contributes to improved therapies for cancer.